Flow Cytometry Core

ABSTRACT – FLOW CYTOMETRY SHARED RESOURCE
The Flow Cytometry (FC) shared resource supports Duke Cancer Institute (DCI) investigators with sorting
and/or analyzing populations of cells based on expression of surface proteins or fluorescent reporters, and
performing batch or single-cell sorting. Flow cytometry allows investigators to analyze parameters such as cell
death, cell cycle, cell signaling, and cytokine production as a function of cellular state or stimulation.
Our Specific Aims are: 1) Maintain state-of-the-art cell sorters and cell analyzers in a cost-effective manner
to meet DCI research needs; 2) Provide expertise in assay development, troubleshooting, and data analysis;
and 3) Train DCI members to use cytometers independently.
The resource maintains four analyzers, four cell sorters, and one image cytometer; analyzers and the image
cytometer are available for self-use, 24 hrs per day and 365 days per year. FC staff is actively engaged in DCI
member research projects, working closely with clients to fine tune their individual experiments and develop
strategies for best outcomes in real time. Based on our extensive experience, we are able to recommend assays,
to help develop and troubleshoot new protocols, and participate in data analysis. The FC’s experienced staff
performs cell sorting, cell analysis, and post-acquisition data handling. These services would otherwise be
unaffordable to investigators, given the costs, time, and training required to purchase, use, and maintain the
necessary equipment. Flow cytometry services are not outsourced easily, given the fragile and time-sensitive
nature of the cell preparations and the experimental protocols.
An important and continuing mission of the FC resource is educating clients to ensure that all DCI members
use the services and technology that best support their research goals. We provide ongoing training in the use
of cytometers and associated software, and maintain a library to disseminate technical information to users. DCI
members receive priority services, and FC operates on a charge-back basis with different rates for staff-run or
self-run work. DCI member laboratories get added value in the form of a 25% discount on usage fees compared
to non-DCI member labs.
In 2018, the FC provided services to 190 investigators, 61% of whom were DCI members who accounted for
78% of total usage and represented all 8 DCI Research Programs. Use of the shared resource by DCI Members,
contributed to 320 publications over the project period, 104 of which were in high impact journals (Impact
Factor>9).